Infant Peanut Allergy Prevention: Understanding and Supporting Caregivers to Achieve Adherence

PROJECT SUMMARY
Peanut allergy (PA) is the most common food allergy in the US; it is also one of the least frequently outgrown
and the leading cause of fatal food-allergic reactions. The landmark Learning Early About Peanut study found
that the ingestion of peanut products in infancy can decrease PA development by over 81%. Thus, in 2017 the
NIAID published the Prevention of Peanut Allergy (PPA) Guidelines. However, implementation of these
guidelines is unique in that they are a reversal of previous guidelines, posing additional challenges for all
stakeholders. For caregivers of young infants specifically, compliance with the PPA guidelines requires them to
understand the changing science around food allergy development, participate in early peanut feeding during
short time window (4-6 months of age), and accept the risks involved with feeding their infant a potentially
allergenic food. While studies involving pediatricians and allergists have been conducted, our current
understanding of caregiver opinions PPA guidelines and our interventions to support caregivers to adhere to
early peanut introduction are limited. Utilizing an established clinical network of over 30 pediatric clinics in Illinois
(primary mentor’s parent grant iREACH), this proposal will evaluate caregiver barriers and facilitators to the
PPA guidelines and investigate the key driving factors for adherence and nonadherence by conducting
qualitative interviews with caregivers of young children. This data will be incorporated into building a distinct
interactive intervention: iCARE (Intervention to Improve Caregiver Adherence Regarding Early Peanut
Introduction). Using web-, mobile-, and/or video-based applications, the goal of iCARE will be to address
caregiver barriers and unmet needs to facilitate early peanut introduction. After following an iterative
prototyping process to develop iCARE with stakeholders and experts, it will be tested among caregivers to
understand its efficacy, acceptability, and feasibility. This will provide preliminary data for an R01 proposal
studying the effectiveness of iCARE in a randomized clinical trial. As caregivers are the ultimate drivers of PPA
guideline implementation, this project addresses a gap in our current approach to PA prevention.
This K23 proposal addresses multiple gaps in Dr. Samady’s research skillset, providing additional training in:
1) qualitative data analysis, 2) behavioral science training, 3) development and evaluation of novel behavioral
interventions. Her primary mentor, Dr. Gupta is a national leader in food allergy prevention studies, her co-
mentor Dr. McGee is a leading expert in qualitative research and professional development, and her co-
mentors Drs. Van Horn, and Pongracic have additional expertise in developing and evaluating behavioral
interventions. Completion of these aims and training goals will support Dr. Samady’s long-term goal of
become an independent investigator and national leader studying infants with atopic disease, focused on
improving the implementation of current food allergy prevention efforts and identifying new prevention
strategies.

Public health relevance
PROJECT NARRATIVE The Prevention of Peanut Allergy (PPA) Guidelines offer a rare opportunity to prevent a chronic and life- threatening condition. As caregivers are the ultimate drivers of the PPA guideline implementation, furthering our understanding of caregiver needs and addressing them with novel interventions that support caregivers is needed. Completion of these studies will augment and strengthen our current food allergy prevention approach.